Administrative Core

ADMINISTRATIVE CORE
ABSTRACT
The Administrative Core proposed represents a continuation of the Administrative Core that has functioned
effectively for this Center through previous cycles of MCRC funding as it transitions to a CCCR. The core will
consist of an internal administrative organization under the leadership of the Center Director, Associate Director,
Director of the Methodology Core and Head of Evaluation. All individuals involved in administration of Center
affairs have experience in their areas of responsibility. There will be two administrative committees, Executive
and External Advisory Committees, which will have defined oversight roles. The Executive Committee will also
meet with a Patient Advisory Group. The CCCR will serve a large dynamic research community and the
Administrative Core will include evaluation of the interactions of this community with core faculty and its services
to be championed by a special research community representative. These committees and the administrative
personnel will be responsible for coordinating, planning and overseeing all CCCR activities in conjunction with
the Center Director. There will also be a formal evaluation program, examining whether the Center is meeting
stated goals and objectives.
The overall objective of this administrative core is to provide oversight and management of the CCCR to ensure
that the Center accomplishes its goals which are to carry out and disseminate high level clinical research
informed both by state of the art clinical research methods and by clinical and biological scientific discoveries.
Among the aims of this core are to ensure allocation of appropriate resources to ensure CCCR progress, to carry
out an outreach program, to ensure that data sharing agreements are in place and utilized, to formally evaluate
whether the CCCR is meetings its goals and objectives and to leverage university and medical campus resources
to enhance the functioning and impact of the CCCR.